Human/Animal Exposure

HUMAN AND ANIMAL EXPOSURE (HUMANE) FACILITY CORE – ABSTRACT
The HUMan and ANimal Exposure (HUMANE) Facility Core provides CEED members with unique and powerful
tools to fulfill the Center’s vision of addressing the environmental health concerns of NJ residents. HUMANE
works with basic and clinical researchers to design and implement experiments that assess how individual or
complex real-world exposures affect biological response indicators linked to adverse health outcomes in humans
and animal models. HUMANE utilizes cutting-edge exposure generation platforms coupled to real-time and timeintegrated
measurement of legacy and emerging environmental/occupational toxicants in the Core’s human
Controlled Exposure Facility (CEF) and the Animal Exposure Facility (AEF). HUMANE also assists CEED
investigators with inhalation exposure studies aimed at examining the interactions between relevant toxicants
and variables such as temperature, humidity, physical activity, psychosocial stress, and pre-existing conditions
or co-morbidities. During the current grant cycle, the Core has strengthened its longstanding expertise and
capabilities in generating controlled gaseous and aerosol exposures by incorporating platforms capable of
generating and characterizing environmental nanoparticles that recapitulate those generated by multiple sources
including wildfires, incinerated micro-nanoplastics, e-cigarettes, and engineered nanomaterials. The capacity of
HUMANE to conduct both controlled animal and human exposure studies facilitates bidirectional translation of
research findings. By studying biological indicators and responses in humans and animals, insight is gained into
mechanisms of disease pathogenesis, which can be targeted for intervention strategies. The Core benefits from
robust interactions with the Translational Research Support Core (TRSC) and the Biological/Environmental
Indicators and Responses (BEIR) Facility Core, which facilitate productive interdisciplinary collaborations and
ensure high standards of QA/QC and safety in study protocols. The Core’s utilization is expected to increase
significantly during the next grant period due to planned investments in mechanical systems and equipment for
the CEF and AEF. The renovation of the CEF will also allow CEED investigators to assess the efficacy of
interventions to reduce the transmission of airborne infections under controlled environmental conditions.